Quantifying Heterogeneities in Dengue Virus Transmission Dynamics

DESCRIPTION (provided by applicant): Current knowledge of dengue virus (DENV) transmission provides, at best, only a partial understanding of a complicated and dynamic system with a public health track record that has more failures than successes. An important part ofthe problems is that the foundation for contemporary interventions includes a series of longstanding, but untested, assumptions based on a relatively small portion ofthe human population; i.e., people who are convenient to study because they manifest clinically apparent disease. Approaching dengue from the perspective of people with overt illness has produced an extensive body of valuable literature. It has not, however, fully embraced heterogeneities in virus transmission dynamics that are increasingly recognized as key missing information in the struggle to control the most important insect-transmitted viral infection of humans. Only in the last 20 years there have been significant efforts to carry out comprehensive longitudinal dengue studies. Our research team was integrally involved in two prominent longitudinal dengue research projects in Iquitos, Peru and Kamphaeng Phet, Thailand. Our proposed POl represents the next crucial step in this line of inquiry. By studying people across the entire continuum of disease, including people with clinically inapparent and mild infections, we aim to quantify heterogeneities in human variables that affect DENV transmission dynamics and prevention. To do this, we will exploit the infrastructure we assembled over the past 14 years at our Iquitos study area. Our POl aims to help fill the void between understanding transmission dynamics and effective disease prevention by defining, for the first time, the contribution of the understudied majority of DENV infected people (the estimated 294 million with inapparent and mild infections) and the contributions of epidemiological, entomological, and socio-behavioral sources of heterogeneity to the dynamics of DENV transmission. By accounting for factors underlying variation in each person's contribution to transmission we will be able to better determine the type and extent of effort needed to prevent virus transmission and, thus, provide new insights for improved dengue prevention. RELEVANCE (See instructions): An estimated 390 million people in 128 at risk countries experience a DENV infection each year. Dengue viruses cause more human morbidity and mortality than any other arthropod-borne virus. It is the most rapidly advancing vector-borne disease in the world and it serves as a model system for transmission of vector-borne pathogens in general. An improved understanding of DENV transmission dynamics, concepts, and theory will fill critical knowledge gaps and significantly improve disease prevention programs.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed work touches on important areas of medical science, aiming to investigate aspects of transmission and virulence at various levels - molecular to population - in order to understand what are among the most important unresolved sources of heterogeneity in dengue epidemiology is variation in the infectiousness of people to mosquitoes. In a non-invasive and natural way, this work will quantitatively define heterogeneity in the capacity of people across the spectrum of dengue disease severity to infect mosquitoes. Clarifying this enigma will facilitate application and evaluation of disease prevention strategies, define surveillance and intervention priorities, and refine the theory of DENV transmission dynamics. PROJECT OVERALL Program Project Principal Investigator (PI): Thomas Scott PROJECT DESCRIPTION (provided by applicant) . We hypothesize that dengue virus (DENV) infected humans vary in their infectiousness to Aedes aegypti and, thus, in their potential for involvement in virus transmission dynamics. We expect that the relative contribution of different people can be predicted by the magnitude and duration of their viremia, which are positively associated with the severity of their disease. Our specific aims are designed to test the following three assumptions of our hypothesis by experimentally exposing Ae. aegypti \.o blood drawn from DENV viremic people: (1) mosquito infection is positively associated with magnitude of viremia, (2) human to mosquito transmission is a function of temporal heterogeneity in viremic profiles (i.e., fluctuations in virus titer across viremias of different duration), and (3) although their infectiousness is relatively low, people with inapparent infections can infect mosquitoes and contribute to virus transmission. Aim 1: Characterize the relationship between magnitude of human DENV viremia and infectiousness to Ae. aegypti. We will test the prediction that there is a positive relationship between increasing magnitude of viremia, severity of disease, and mosquito infection by measuring infectiousness of viremic blood from naturally infected people to mosquitoes. We expect that there will be a threshold below which virus transmission to mosquitoes does not occur and a negative relationship between viremia titer and duration of extrinsic incubation in mosquitoes. Aim 2: Describe temporal dynamics of human DENV infectiousness to Ae. aegypti. We will determine whether the potential for humans to transmit DENV to mosquitoes changes over the course of a person's viremia. We will use multiple, sequential blood draws from the same naturally viremic individuals to monitor temporal dynamics in mosquito infection. We expect that potential for mosquito infection will be the product of duration and varying magnitudes of viremia, which will be positively associated with disease severity. Aim 3: Determine the relative capacity of people with inapparent DENV infections to transmit virus to Ae. aegypti. We expect that although mosquito infection is positively associated with severity of disease, we will find that viremia during inapparent infections is sufficiently high and lasts long enough to infect mosquitoes and contribute to DENV transmission. Suggested clarification.